Characterization Of Cell Surface Molecules Important For

We proposed a role for the extracellular matrix component, laminin-2, and its integrin receptor, VLA-6 in thymocyte development. The characterization of two dystrophic mouse strains with different defects in laminin-2 allowed us to examine this proposal in vivo. Mice deficient in laminin-2, dy/dy, show a significant reduction in thymus size ,alterations in thymic architecture,and number of thymocytes compared to normal littermates. Examination of the CD4/CD8 populations in dy/dy thymi showed large relative increases in the DN and SP populations and a significant decrease in the DP population. Further examination of the DN population for CD44 and CD25 expression showed a remarkable decrease in the more mature pre-T cell populations. Analysis of apoptosis in dy/dy thymi revealed a significant increase in apoptotic DN thymocytes in the capsule and subcapsular regions. Interestingly, thymocyte development appeared to proceed normally in dystrophic mice expressing a mutant form of laminin-2, dy2J, as well as, in fetal and neonatal dy/dy mice. We propose that laminin-2 plays an active role in thymocyte development by delivering cell survival and differentiation signals at specific stages of development in young adult mice. Thymus specfic beta 1 integrin knockout mice are being prepared to analyze in detail the role of beta 1 integrins in development of T cell responses.